Characterization of the structural and molecular properties of propagating tau in vitro and in vivo

Project summary/abstract.
Tau protein accumulates into pathogenic deposits in many neurodegenerative diseases, including Alzheimer
disease (AD) and some forms of Gerstmann-Sträussler-Scheinker disease (GSS). Using cryo-electron
microscopy (cryo-EM) recent groundbreaking studies have determined the existence of multiple tau
conformers, which may differ between tau diseases. The tau aggregates in AD and GSS contain all 6 isoforms
of tau, and both have been ultrastructurally determined to contain paired helical filaments (PHFs). However in
AD, there exists an ultrastructural polymorph to PHFs, comprised of the same amino acid sequence but a
differing interface, named straight filaments (SFs). These SFs are not found in GSS, nor is it known why tau
would fold into PHFs versus SFs in AD. This means that therapeutics designed to target specific tau
conformers may not be suitable for all tau polymorphs within a disease. Numerous studies have demonstrated
that tau acts in a ‘prion-like’ manner, templating the misfolding from pathogenic ‘donor’ to naïve ‘receiver’ tau,
in both in vitro and in vivo models of tau diseases. However, how donor tau acts as a template to receiver tau
is not yet known; the mechanism(s) of which would provide a myriad of targets to reduce tau propagation and
thus disease dissemination throughout the brain. Our study aims to answer the following questions: is the
structure of tau conferred from donor to receiver tau in vivo, and therefore are our in vivo models of
neurodegeneration valid for investigating tau propagation (aim 1)? How are the numerous post-translational
modifications (PTMs) on tau relevant to tau polymorph formation (aim 2b), and are these PTMs recapitulated
from donor to receiver tau both in vivo (aim 2a) and in vitro (aim 3)? What are the gene changes that are
occurring in a circuit of diseased brain cells, and are these changes spreading to both anterogradely and
retrogradely connected cells (aim 3)? Using novel in vivo and in vitro systems including custom microfluidic cell
culture devices, cryo-EM imaging and analysis, mass spectrometry and RNAseq, we aim to answer these vital
questions and thus identify future targets for preventing tau propagation.

Public health relevance
Project Narrative Although most studies in Alzheimer disease (AD) so far have focused on amyloid β, interest in tau is growing because of the discovery of the central role of tau in neurodegeneration and the difficulties associated with the targeting of amyloid β to develop mechanism-based treatments for AD. The main goals of this project are to elucidate the structural basis and pathological mechanisms implicated in tau propagation in vivo and in vitro using novel technologies and model systems. The investigation of what drives the specificity of tau conformers in tau pathology is an essential step toward the design of novel diagnostic and therapeutic molecules.